Identifying the role of MrgprB4-lineage neurons in social touch and oxytocin circuit activation

PROJECT SUMMARY
The rewarding nature of social touch is critical for communicating physical and emotional support, and can even
be anxiolytic in therapeutic forms of touch such as massage. Touch-induced affiliative emotions and anxiolytic
benefits are generally attributed to the release of the hormone oxytocin (OT) from the paraventricular nucleus of
the hypothalamus (PVH). However, the underlying neurobiological relationship between social touch and OT
release, including the class of peripheral mechanoreceptors that convey this information to the central nervous
system, is unknown. Peripheral mechanoreceptors called C-tactile afferents (CT afferents) detect stroking touch
in humans. However, whether activation of CT afferents underlies central OT release in social scenarios remains
unclear, largely because experimental manipulation of CT afferents has proved challenging. In mice, an
anatomically analogous population of mechanoreceptors are marked by expression of mas-related G-protein
coupled receptor B4 (MrgB4), providing a gateway to dissect mechanisms of social touch in a genetically
tractable model organism. In fact, my preliminary data suggest that transdermal optogenetic activation of MrgB4-
lineage neurons increases oxytocin expression in the PVH, cFos expression in the medial preoptic area (mPOA)
(which is active during female sexual behavior), and induces a change in posture that could represent a reaction
to social mechanical pressure. Therefore, I hypothesize that activation of MrgB4-lineage neurons mediates
touch-dependent social behaviors and is sufficient to activate hypothalamic OT neurons. I will test this hypothesis
in two specific aims. In Aim 1 I will determine whether MrgB4-lineage neurons are necessary and sufficient for
sexual behavior, a highly touch-dependent social behavior. To test the necessity of these neurons for sexual
behavior, I will assess whether females with genetically ablated MrgB4-lineage neurons exhibit a deficit in sexual
receptivity to male mounts compared to littermate controls. In a complementary experiment, I determine whether
chemogenetic activation of the MrgB4-lineage neurons is sufficient to facilitate sexual receptivity. These two
experiments will define the role of MrgB4-lineage neurons in a highly touch-dependent social behavior. In Aim
2 I will determine whether optogenetic or natural tactile stimulation activates OT+ PVH neurons in freely behaving
mice. To determine if the observed increase in OT mRNA represents a MrgB4-lineage neuron-induced activation
of OT neurons in vivo, I will use fiber photometry to record from OT+ PVH neurons during simultaneous
optogenetic activation of MrgB4-lineage neurons in the back. To assess the relevance of OT+ PVH neurons to
social touch, I will use fiber photometry to record from OT+ PVH neurons in females during sexual behavior.
Collectively, this proposal will define the role of a population of molecularly-defined mechanoreceptors in social
touch and OT+ neuron activity, thereby addressing the missing link between touch and OT release.
Understanding the neurobiological mediators of social touch will ultimately facilitate discovery of novel
therapeutic targets for somatosensory-mediated anxiolytic approaches.

Public health relevance
PROJECT NARRATIVE Social touch can communicate relational love and support and even reduce anxiety in the form of therapeutic massage, two benefits generally attributed to oxytocin release in the brain. This proposal seeks to identify the mechanosensitive touch neurons in the skin that detect social touch and determine whether selective activation of these neurons is sufficient to induce oxytocin activity. Defining the relationship between peripheral mechanoreceptors and oxytocin will be crucial in the discovery of somatosensory-targeted treatments for anxiety disorders.